Title: Quality Control of Electronic Pathology (E-path) Results (Stage appropriate cases)POP: 09/12/2014-09/11/2015

Iowa will assess quality and completeness of electronic pathology (E-Path) results for colorectal cancer only. Iowa will collect electronic pathology results for KRAS mutation test results from colorectal cancer case records. Iowa will assess the completeness of these records and document compliance with recommended testing.